Rhode Island IDeA Network of Biomedical Research Excellence

PROJECT SUMMARY
The overarching goal of Rhode Island-IDeA Network of Biomedical Research Excellence (RI-INBRE) is to
improve institutional capacity for biomedical research excellence and to expand student experiential training
opportunities in the State of Rhode Island. We will accomplish this goal by growing statewide institutional
research capacity, supporting early career research faculty development, and by providing structured and
mentored research training experiences for undergraduate and graduate students and postdoctoral fellows. RI-
INBRE is comprised of two research-intensive institutions, the University of Rhode Island and Brown University,
five primarily undergraduate institutions (PUIs)(Bryant University, Providence College, Rhode Island College,
Roger Williams University, and Salve Regina University), and one community college, the Community College
of Rhode Island. The University of Rhode Island (URI) is the lead institution of RI-INBRE and serves as the major
network administrative and assessment hub. RI-INBRE will be composed of five major core components: the
Administrative Core, the Bioinformatics Core, the Centralized Research Core Facility (CRCF) Core, the Training
Core, and the Developmental Research Project Program (DRPP) Core. Since its inception in 2001, RI-INBRE
has had a transformative impact on the biomedical research environment throughout Rhode Island and, in
particular, at several of the network PUIs. We have accumulated a wealth of experience on how to develop and
enhance a biomedical research environment through targeted investment and structured mentoring. The
implementation of a successful research capacity building program requires sustained and long-term strategies.
During the renewal period, we will build upon our successes to date and implement several new innovative
strategies to expand the impact of the program and to develop a broadly inclusive, productive, and sustainable
culture of biomedical research excellence in Rhode Island. The Ocean State is on the cusp of becoming a major
player in biomedical research. Continued funding of RI-INBRE is essential to maintain a dynamic and well-trained
biomedical workforce, to continue to promote biomedical research sea-changes at the network PUIs, and to
promote investment and entrepreneurship in the biomedical sciences in Rhode Island.

Public health relevance
The RI-INBRE program strives to improve the biomedical research infrastructure and training capacity in Rhode Island, specifically in the areas of Cancer, Neuroscience, and Environmental Health Sciences.